Minipuberty of infancy: a critical period for growth and development in girls

PROJECT SUMMARY/ABSTRACT
Age at onset of breast development (thelarche), a marker of pubertal onset in girls, has decreased dramatically
in the past half-century. This trend has important public health implications as earlier puberty in girls is associated
with adverse health consequences across the lifecourse, including increased risks of cardiovascular disease and
breast and other hormonal cancers. Pubertal onset is triggered by the re-activation of the hypothalamic-pituitary-
gonadal (HPG) axis in childhood, a process that is poorly understood. Increased understanding of HPG axis
activity and function in early life is crucial for identifying risk factors for early puberty that may be amenable to
interventions. The HPG axis is active for a brief period during infancy, known as minipuberty, before it is silenced
until pubertal onset. The function of HPG axis activity during minipuberty in girls remains unclear. In this K99/R00
research, I will examine the overarching hypothesis that minipuberty is a critical window of programming with
short- and long-term effects on endocrine-sensitive processes including growth, breast development, and
pubertal development. To do so, I will use data from 136 girls in the Infant Feeding and Early Development
(IFED) study, a prospective cohort of infants previously followed from birth to age 9 months with repeated
assessments of serum sex steroid concentrations, anthropometrics, and ultrasound measures of breast bud
diameter. In the K99 phase, I will examine longitudinal associations of sex steroid concentrations during
minipuberty with breast bud diameter (Aim 1) and velocity of linear growth and weight gain into late infancy (Aim
2). I will also conduct a longitudinal follow-up of the former IFED infants (born 2010-2013) as they transition
through pubertal maturation. Combining these unique repeated measures data captured during minipuberty and
adolescent puberty, I will evaluate whether sex steroid concentrations during minipuberty are associated with
the timing of pubertal development, as assessed by ages at thelarche and menarche, and sex steroid
concentrations across the pubertal transition (Aim 3, R00). This research will provide novel insights into the role
of minipuberty in shaping breast development and growth into adolescence, which has implications for the
etiology, screening and ultimately prevention of early puberty and its long-term sequelae. To achieve these
research aims, I will combine prior epidemiologic training with new experiential and didactic training in pediatric
and reproductive endocrinology, advanced statistical methods for longitudinal biomarker data, cohort
development and implementation, and professional development. My K99 training will take place within the
interdisciplinary environment of the Intramural Research Program at the National Institute of Environmental
Health Sciences with the support of a mentoring team of outstanding scientists. This career development award
will provide me with the necessary experience to launch my independent research program focused on applying
innovative epidemiologic approaches to understand how exogenous and endogenous hormonal factors during
critical periods of early life affect growth, breast development, and women’s health across the lifecourse.

Public health relevance
PROJECT NARRATIVE The function of minipuberty, the brief period of hypothalamic-pituitary-gonadal axis activity in infancy, in girls remains unclear. The proposed research will use data from a prospective infancy cohort to examine the short- and long-term effects of the sex steroid surge during minipuberty on infant breast development, infant growth, and the timing of puberty in girls. Understanding the biologic role of sex steroids during minipuberty in growth and female development may lead to opportunities for identifying infants and girls at high risk of early puberty and for primary prevention of early puberty and its long-term consequences by serving as a mechanistic target through which modifiable factors influence pubertal onset.